Project 3: Demethylation of HPV-associated head and neck cancer to trigger APOBEC synthetic lethality and enhance immune response

SUMMARY
Human papillomavirus (HPV)-associated neck squamous cell carcinoma (HNSCC) represents an increasing
proportion of HNSCC. The incidence of HPV+ HNSCC has dramatically increased over the last 2 decades and
in 2012 surpassed uterine cervical cancer as the most common HPV-related malignancy in the U.S. Despite
the HPV vaccine, it is estimated that the “epidemic” of HNSCC caused by HPV will not diminish until 2060.
HPV+ HNSCCs occur in younger individuals and prognosis for patients with these tumors is better compared
to patients with classical HNSCC; however, ~25% of patients recur with few effective therapeutic options.
Based on observed hypermethylation of HPV+ HNSCC from TCGA, and understanding that HPV uses
hypermethylation to impede the innate immune response, effects of the demethylating agent, 5-azacytidine (5-
azaC), were tested on HPV+ HNSCC. We found that HPV+ HNSCC cells in culture and xenografts are
sensitive to 5-azaC, and that 5-azaC caused double strand breaks (DSB) that were not observed after 5-azaC
therapy in HPV-negative HNSCC, even with much higher doses. We found that following 5-azaC therapy,
APOlipoprotein B mRNA-Editing enzyme Catalytic polypeptide 3B (APOBEC3B) was associated with
chromatin in HPV+ HNSCC, but not HPV-negative cells. CRISPR knockdown of A3B prevented DSB and
protected cells from 5-azaC-induced death. Despite being required for DSBs and cellular toxicity caused by 5-
azaC, A3B was also required for clonogenic survival of untreated HPV+ HNSCC. These data showing that A3B
is required for survival of HPV+ HNSCC cells, but that following demethylation A3B mediates toxicity and DSB.
In addition, 5-azaC therapy increased type I interferon signaling as measured by increased expression of
interferon-stimulated genes. These exciting pre-clinical data led to a window trial of 5days of 5-azaC. Analysis
of tumor specimens confirmed in vitro data showing that 5-azaC resulted in cellular toxicity. Immunofluorescent
staining of an HPV+ patient tumors pre- and post-5-azaC showed a marked increase in tumor-associated
lymphocytes, possibly driven through activation of type I interferon combined with increased expression of
neoantigens. In this YHN-SPORE project, we hypothesize 5-azaC therapy will enhance response to nivolumab
(Nivo) through its ability to cause cell death, increase neoantigen expression, increase A3B-driven mutational
load, and enhance T cell infiltration through increased type I interferon signaling. These hypotheses will be
tested using established and novel in vitro assays, as well as through examination of pre- and post-therapy
tumor specimens from a 3-armed clinical trial. In Aim 1, tumor specimens from the SPORE window trial will be
analyzed to determine effects of 5-azaC, Nivo, or the combination on cell death, cell proliferation, immune
infiltration and immune activation. Aim 2 will employ standard and novel assays to explore the role of A3B in
cellular toxicity exposed by 5-azaC therapy. In Aim 3, we will determine effects of 5-azaC on activators of
immune recognition and response in the presence or absence of Nivo.

Public health relevance
NARRATIVE The number of head and neck cancers caused by the human papillomavirus are dramatically increasing, but current therapies can cause lifelong side effects, and patients with recurrent disease have few effective treatment options. We have identified that demethylation therapy increases immune response in these tumors, and that they are sensitive to demethylation dependent on expression of a cytidine deaminase, APOBEC3B, that ironically is required for survival of untreated cancer cells. In this project, we will conduct a trial and use trial samples to further determine if demethylation enhances response to immune checkpoint inhibitors as a new therapy for human papillomavirus-associated head and neck cancers.